Society for Research on Nicotine & Tobacco 2023 Annual Meeting

PROJECT SUMMARY
The Society for Research on Nicotine and Tobacco (SRNT) is the only international scientific society dedicated
exclusively to the field of nicotine and tobacco research. SRNT has more than 1,200 members from over 40
countries, with approximately 80 percent of those members being affiliated with U.S. research, advocacy,
pharmaceutical, and related organizations. The overall objective of the SRNT Annual Meeting is to stimulate
advancement in the field of nicotine and tobacco research through the presentation of timely and cutting-edge
research, discussion, and networking. It is the hallmark conference in the field where investigators, advocates,
and policymakers can learn about the latest scientific findings, including novel products in the marketplace and
effective interventions and policies to reduce tobacco use in the U.S. and in other countries. The SRNT Annual
Meeting provides a crucial venue for the presentation of the rapidly evolving tobacco regulatory science
research findings to the major keyholders in research and policy. The aims of this conference grant are to: 1)
ensure that tobacco regulatory science content is presented in ways that are maximally informative to FDA and
to researchers in the field; and 2) to support the career of trainees and early career investigators in tobacco
regulatory science via opportunities for special oral sessions, professional development forums, travel awards,
and other recognition. To meet both aims, SRNT’s Program Committee will meet regularly throughout the year
to plan the content and format of the SRNT 2023 Annual Meeting, aligning the presentation of scientific content
with research priorities in the Tobacco Regulatory Science Program (TRSP). The Committee will curate paper
sessions on specific topics that highlight advances in the area, foster scientific discussion and debate, and
stimulate collaboration across researchers. The conference grant will also support 10 travel awards for trainees
and early career investigators presenting on content related to the FDA and NIH Tobacco Regulatory Science
Program research priorities. These interactions will facilitate the development of novel questions and
approaches to tobacco regulatory science research and support the careers of future researchers in tobacco
regulatory science.

Public health relevance
PROJECT NARRATIVE The SRNT Annual Meeting is an optimal venue for the presentation of novel findings from tobacco regulatory science research projects and networking across scientists in this emerging field. The aims of this conference grant are to: 1) ensure that tobacco regulatory science content is presented in ways that are maximally informative to FDA and to researchers in the field; and 2) to highlight the work of trainees and early career investigators in tobacco regulatory science via special oral sessions, professional development forums, travel awards, and other recognition.